The Role of the Fructose-1,6-Bisphoshatase 2 and c-Myc Interaction in Sarcoma Progression

PROJECT SUMMARY
Soft tissue sarcomas (STSs) are diverse mesenchymal tumors that occur within connective tissues such as
muscle, fat, and cartilage. STS is a highly heterogeneous malignancy with over 70 genetic and histological
subtypes. In addition, high rates of recurrence and lack of effective treatment for patients emphasize the need
to identify novel therapeutic vulnerabilities common to multiple STS subtypes. Metabolically, STS tumors
consistently exhibit high rates of glucose uptake and robust hypoxia gene signatures in patients. Therefore, we
focused on fructose-1,6-bisphosphatase (FBP), a rate-limiting enzyme in gluconeogenesis, to combat the typical
glycolytic dependence of STS. In previous studies, we showed that FBP2, the muscle-specific isoform of FBP,
is severely downregulated in several prevalent STS subtypes. Surprisingly, FBP2 re-expression in STS in vivo
opposes sarcoma progression through two spatially distinct mechanisms in the cytoplasm and the nucleus. FBP2
restoration decreases cytosolic glycolytic flux while nuclear FBP2 directly binds to c-Myc, a transcriptional
regulator of growth and metabolism. This interaction attenuates c-Myc-dependent expression of TFAM, a key
regulator of mitochondrial biogenesis, thereby inhibiting oxidative phosphorylation. These mechanisms, at least
in part, contribute to the ability of re-expressed FBP2 to suppress tumor growth in murine STS models. However,
my preliminary data suggest that nuclear FBP2 may also directly regulate other c-Myc cell cycle target genes
CDK4 and AURKA to contribute to STS suppression. Moreover, how FBP2 regulates c-Myc and the sites of
FBP2/c-Myc binding are not known. Recent studies suggest that FBP2 oligomerization and conformation may
also play an important role in FBP2's nuclear-to-cytosolic shuttling, and reveal new binding sites for other proteins
in the nucleus like c-Myc. Therefore, I hypothesize that the exposed N-terminal regions of tetrameric FBP2
complexes bind directly to c-Myc, contributing to STS suppression by inhibiting both TFAM and cell
cycle regulators. In Aim 1, I will map the sites of interaction between FBP2 and c-Myc and determine whether
the tetrameric state of FBP2 is necessary for binding. In Aim 2, I will explore the functional outcomes of the
FBP2/c-Myc interaction in sarcoma, including the regulation of cell cycle genes AURKA and CDK4. Together,
this proposal will provide more insight into the recently discovered nuclear functions of FBP2 to create novel
therapies for a diverse set of genetically heterogeneous sarcomas.

Public health relevance
PROJECT NARRATIVE: Soft Tissue Sarcomas (STSs) are a rare group of mesenchymal tumors in adults that are resistant to conventional treatments such as chemotherapy, due to their extensive heterogeneity. A common feature in many soft tissue sarcomas is altered cellular metabolism due to downregulation of the rate limiting enzyme in the formation of glucose. The proposed research will explore the mechanisms of how re-expression of this enzyme effects STS progression, providing more mechanistic insight for novel sarcoma therapies.